Role of SOX9 mammary stem cell factor in metastasis

Project Summary (Project 2)
Metastasis remains a critical problem in cancer treatment. While the early steps of the metastatic
cascade are well-characterized, the mechanisms underlying late steps of metastasis, including
extravasation, survival and growth at distal sites, remain poorly understood. Breast cancer is a
heterogeneous disease comprised of functionally diverse cancer cells, among which a minor
subset of cells is highly tumorigenic and shows stem-like properties. These stem-like cells are
believed to drive tumor regrowth and propagation at the distal sites. However, genetic programs
that control cancer stemness in metastasis remain to be determined. The master regulators of
normal stem cell programs are thought to be hijacked by CSCs. We and others have recently
identified the transcription factor SOX9 as a key regulator for stemness that contributes to
metastasis. Using mammary tumor models expressing a novel SOX9 reporter, we found that
SOX9-high cancer cells are enriched in tumor-initiating and metastasis-initiating abilities.
Interestingly, early-stage metastases contain a high frequency of SOX9-high CSCs relative to
primary tumors, suggesting the metastatic niche promotes CSC expansion or induction leading to
distant metastasis. However, the exact cell-intrinsic/-extrinsic mechanisms that regulate SOX9-
mediated stemness and the signaling pathways that contribute to metastatic outgrowth
downstream of SOX9 remain unknown. Our preliminary data identified a novel role of ROS-
upregulated HIF1a in inducing SOX9 expression. In addition, results from Project 1 and 3 suggest
that cancer-stromal cell interactions promote stemness through paracrine/juxtacrine signals. Based
on the cumulative preliminary evidence, we hypothesize that SOX9-driven stemness is
potentiated by intrinsic and extrinsic signals in the metastatic niche, leading to
extravasation and metastatic outgrowth. We will determine the role of ROS/HIF1a signaling in
potentiating SOX9-driven stemness (Aim 1), understand how paracrine/juxtacrine signals from
macrophages and platelets regulate SOX9-driven stemness (Aim 2), and define the downstream
pathways mediating the action of SOX9 in extravasation and metastatic growth (Aim 3).

Public health relevance
Project Narrative (Project 2) Metastasis is the main cause of cancer death. While we have significant understanding of biological events occurring in the primary tumor and at the early steps of metastasis, much less is known about how late steps of metastasis at distant organs are regulated. The proposed work will study how key stem cell factors promote these late steps of metastasis. Our findings will help develop strategies for preventing and/or treating metastatic disease.